Caribbean Primate Research Center Program

PROJECT ABSTRACT:
A renovation of the Behavioral/Environmental Enrichment Unit's infrastructure at
the Sabana Seca Field Station is urgently needed to support any further colony expansion. This
unit aligns with our commitment to the well-being of our animals. With this administrative
supplement to the parent grant, we aim to renovate and modernized this Unit.

Public health relevance
PROJECT SUMMARY: The major goal of this administrative supplement application for the Parent P40 Grant of the Caribbean Primate Research Center (CPRC) is to renovate the Behavioral/Environmental Enrichment Unit (BEEU) area at the Sabana Seca Field Station. This in turn is essential to support animal well-being as well as any future expansion of the Center's Indian origin rhesus macaque colony. It is well-known that species-specific plans for housing and management should be developed in any NHP facility. Such plans should also include strategies for environmental enrichment. The CPRC is one of the most important national resources for any research program using indian- origin (IO) rhesus macaques with no history of admixture and with well-defined genetic and virological backgrounds. Since 1938, the Center has supplied the scientific community with Indian origin rhesus macaques with known backgrounds and of the same genetic pool for use in studies of basic biology and diseases. In the last three years (2020-2023), 1,234 animals have been allocated from the CPRC program in support of NIH-high priority HIV/AIDS-research, mainly R01, P01, U01- funded academic investigators and NIAID-DAIDS-SVEU programs in USA. The CPRC has vast experience in the establishment and maintenance of rhesus macaque breeding colonies. The animal care and use program of the CPRC is in compliance with the directives established by the Animal Welfare Act (AWA), PHS and other agencies. The Center is AAALAC fully- accredited. The population management program has been designed to optimize the health and well-being of the monkeys, enhance the value of the colony for research, and provide healthy animals to the scientific community for a variety of studies. The Center is in the urgent need of renovating the behavior /environmental enrichment infrastructure severely affected by Hurricane Maria. This renovation will support the CPRC's plan for future expansion as well as the parent grant's objective of producing and distribute valuable genetically and virologically characterized rhesus monkeys for the research community.